Clinical Investigation and Precision Therapy

CLINICAL INVESTIGATIONS AND PRECISION THERAPEUTICS PROGRAM
PROJECT SUMMARY/ABSTRACT
The Clinical Investigations and Precision Therapeutics (CIPT) Program provides a translational bridge between
the basic and population science Programs and the clinic, while conducting its own focused research. The CIPT
Program is built upon the following aims: 1) targeting metabolic, cell death and survival pathways in cancer; 2)
targeting DNA repair and cell cycle checkpoint abnormalities in cancer; 3) targeting the immune
microenvironment in cancer in close collaboration with CMI investigators; and 4) investigating markers of
response and resistance to cancer therapy. The Program seeks to fulfill these aims by: 1) translating outstanding
science across the center into early phase trials; 2) developing novel diagnostic, prevention, and therapeutic
strategies; and 3) promoting bidirectional translation from bench to bedside and back.
The CIPT Program consists of 80 Members from 21 Departments, 8 Schools, and 2 Universities. The CIPT
Program has recruited 46 new Members since the prior NCI site visit. As of November 1, 2022, CIPT Program
Members have 19 NIH R01 or equivalent grants (with 15 different, independent PD/PIs), including 21 multi-
PI projects. CIPT research is supported by $5.3 million in cancer-relevant funding (including $4.0 million in
funding from the NCI, a 56% increase since the last review). CIPT members published 988 peer-reviewed,
and cancer-relevant papers with 204 appearing in high-impact journals (IF>10).
At the prior competitive renewal, the CIPT Program was rated Excellent to Outstanding. In response to
opportunities for improvement identified by the review team, the CIPT Program increased its peer-reviewed
funding and multi-PI grants and number of Members leading clinical trials; successfully competed for multi-project
grants including P01s and U-grants; maintained a high level of successful scientific and clinical translation from
the Molecular Tumor Board (MTB) and Precision Oncology Initiative, and initiated the Committee to Expedite
Translational Initiatives (CETI), which meets regularly to identify, prioritize, and fund specific scientific projects
that have greatest potential for successful clinical translation. In addition, a dedicated CIPT Community Outreach
and Engagement (COE) Program Liaison meets regularly with community members, COE leadership and CIPT
investigators to enhance dialogue and increase the focus on catchment area relevant research.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)